Combined bioprinting with stem cell technology to regenerate skin burn wounds

PROJECT SUMMARY
The skin (epidermis) is responsible for protecting the body and works as a specialized, vital defensive barrier.
Upon injury, the immediate response of the epidermis and its stem cells aims to reestablish local homeostasis.
Extensive injuries, often observed in burn patients, compromise the epidermal homeostasis, which leads to
dehydration, possible severe infections, and death. New therapeutic strategies designed to improve healing and
burn injuries are critically needed. Our translation-focused innovative strategy aims to develop mechanism-based
and material engineering-driven therapies to augment epidermal healing. Here, we are developing novel and
exciting biodegradable scaffolds for the controlled delivery of key recombinant proteins and cells to positively
reestablish an epidermal barrier and wound closure. We propose to study how this novel therapeutic strategy
affects the skin stem cells and wound healing process. Furthermore, we will determine the therapeutic
effectiveness of 3D tissue engineering on burn wounds using bioprinting technology. Our positive results will
improve the mechanistic understanding of how patient-originated stem cells and epidermal cells along with 3D
bioprinting contribute to the healing of burn wounds. By accomplishing these specific aims, we will aid in the
management of burn patients, using limited donor tissues and help to reduce burn patients’ recovery time.

Public health relevance
Relevance: The skin is the largest organ in the body, and its primary purpose is to prevent the loss of body fluids and to protect against biological, physical, and chemical insults by maintaining a functional epithelial barrier. Compromised skin barrier due to burns occurs in more than 1 million US citizens annually and is the seventh cause of injury death in the US alone. Our research focuses on developing new therapies that combine biomaterials capable of delivering homogeneous cell suspension of epithelial cells lifted from small amounts of donor tissues to burn sites.